Facility Core

SUMMARY/ABSTRACT: FACILITY CORE
The Facility Core (FC) for the Great Lakes Center for Fresh Waters and Human Health, hosted by the
University of Michigan (UM), will provide support services for four individual projects and the Community
Engagement Core. The FC is divided into three subcores: nutrient analysis, led by the Stone Laboratory, Ohio
State University; cyanotoxin analysis, provided by SUNY-College of Environmental Science and Forestry
(ESF), University of Toledo (UT), and Wayne State University (WSU); and DNA sequencing and data synthesis
at UM. Each of the participating universities has extensive experience in their respective areas of analytical
expertise. All cores from the prior award period remain as members of the proposed renewal Center, which will
ensure continuity in data integrity. New to this application, we have greatly expanded the mass spectrometry
analysis portion of the core to include both new facilities available at SUNY-ESF and extensive new
capabilities available at WSU and UT. DNA sequencing has been moved from a private company via the
Administrative Core to a UM core via the FC in this renewal to better integrate data across the different
projects.